Development of Broad Coronavirus Immunity Targeting the Fusion Peptide

Project Summary
This revised application was originally responding to the Emergency Award ‘Rapid Investigation of Severe
Acute Respiratory Syndrome Coronavirus 2 (SARS-CoV-2) and Coronavirus Disease 2019 (COVID-19)’
submitted through PAR-20-177. However, we are submitting the revised application, upon advice from NIH, to
the parent PA-20-195 with a due date of Nov 16th 2020. The application is titled ‘Development of Broad
Coronavirus Immunity Targeting the Fusion Peptide’. The assembled team brings together highly
complementary expertise in order to develop a unique coronavirus vaccine approach to provide more effective,
focused and broadened humoral immunity. This proposal focuses on the fusion peptide site of
vulnerability as it has been understudied, it is highly conserved and recently been identified as an
epitope of neutralizing antibodies in human convalescent sera. The project aims are: (1) Develop pan-
coronavirus fusion peptide nanoparticle and trimer immunogens (2) Develop immunization regimes to induce
broadly neutralizing antibodies using nucleic acid delivery.

Public health relevance
Project Narrative Despite the astonishing effectiveness of vaccines in relieving humans from the burden of infectious diseases, coronaviruses have eluded such efforts with devastating effects. Immune defenses need to be specifically triggered to fully exploit vulnerabilities of coronaviruses. This proposal will explore ways to build protective immune responses and significantly advance development of medical countermeasures against COVID-19 and other human coronaviruses.